Cellular and circuit basis for flexible control of sensory acquisition

Project Summary
The goal of this project is to study the cellular and circuit bases of motor control for active sensation. Accurate
and context-specific movements of sensors is critical for acquiring sensory information during behavior. This
requires coordination of ongoing sensory information and motor output, often across different levels of
processing in the brain. However, these circuits can be complicated and difficult to access at the molecular and
cellular level. Studying their function in either normal or disease states is thereby a major challenge. Fruit flies
(Drosophila melanogaster) actively tune mechanosensory input using movements of their two antennae, and
our recent work has expanded genetic access to the sensory and motor circuits in this small circuit model
system. With a broad suite of genetic, physiological, and neural connectivity tools to study neural circuits in
Drosophila, our project seeks to reveal mechanisms of motor control for sensation at the cellular and circuit
levels. First, we will establish the role of a newly discovered set of antennal premotor neurons in controlling
specific antennal movements during behavior. We will use a combination of optogenetics and in vivo
electrophysiology in tethered, flying flies to determine how cellular activity in these neurons coordinates
movement. Using supervised machine learning tools to analyze antennal video data recorded simultaneously
with neural recordings, we will quantify the activity of individual genetically identified neurons in response to
external deflections of the antennae and to self-generated motions during flight. Next, we will directly measure
how actively controlled antennal movements alter sensitivity of an antennal mechanosensory neuron class,
using a combination of in vivo electrophysiology and mechanical manipulations of active antennal movements.
Finally, we will identify and characterize new descending neurons that project to antennal motor neurons in the
central brain before synapsing onto motor output regions controlling wing and leg movements. We will use
stochastic optogenetic activation with quantitative behavior analysis to map their role in producing distinct
antennal motions, then evaluate the functional connectivity of these neurons with antennal motor neurons
using optogenetic activation and intracellular recordings in intact, behaving animals. Together, this work will
elucidate cellular strategies for coordinated tuning of sensation during behavior.

Public health relevance
Narrative The goal of the proposed research is to understand how multiple levels of motor control enable the brain to shape our behavior to our sensory experience of our surroundings. Here we will study specific neural circuitry in the fruit fly antennal mechanosensory system to probe motor behavior in response to active sensory information gathered by the antenna during behavior. Discoveries made in our model system will aid our understanding of how these brain circuits operate in the brain, and how disruptions in these same circuits cause human disease.